Deciphering molecular mechanisms underlying vertical transmission of Listeria monocytogenes

Abstract Pregnant women are more likely to be infected with the intracellular pathogen Listeria monocytogenes (Lm) than the general population, and the bacterium can be vertically transmitted leading to fetal infection and pregnancy loss. Despite its

Public health relevance
Project Narrative Pregnant women are 10 times more likely to be infected with the food-borne pathogen Listeria monocytogenes than non-pregnant adults, and fetal death occurs in 20-60% of cases. This proposal aims to understand the mechanisms by which the bacterial virulence factor InlB enhances L. monocytogenes invasion of the placenta and transmission from mother to fetus. The knowledge gained from this proposal may eventually lead to improved strategies for treating L. monocytogenes infections and a better understanding of vertical transmission in other infectious diseases.